CARDIOVASCULAR HEALTH STUDY (CHS)- CORE STUDY OPERATIONS

The Cardiovascular Health Study (CHS) is a cohort study of risk factors for coronary heart disease and stroke in a diverse population-based sample of men and women aged 65 years or older at baseline. The main objective is to identify factors related to the onset and course of heart disease and stroke. The original cohort of 5201 elderly were recruited in 1989-1990; and in 1992-1993, 687 additional African American participants were recruited and examined. At baseline, participants answered questionnaires and were examined, including carotid ultrasound, echocardiography, and pulmonary function. During follow-up, 1990-1999, many baseline examination components were repeated, and a few new ones, including cranial
magnetic resonance imaging (MRI), were added. The main CHS clinic exams ended in June 1999. An additional examination was conducted in 2005 and an in-home visit is currently in progress. Since June 1999, two phone calls per year to participants have identified events and collected limited information, including hospitalizations and information about cardiovascular events. In 2005, when the NHLBI ceased funding for events data collection and adjudication, an investigator-initiated grant (HL080295, converted to a cooperative agreement) supported these activities until 2015. In 2015, when the NHLBI ceased funding infrastructure for CHS, an investigator-initiated grant (HL130114, converted to a cooperative agreement) continued support for the contact with participants and for the support of working groups. This proposal is written in response to the NHLBI RFP No.75N92018R0090 “Cardiovascular Health
Study (CHS)” which seeks to move the CHS infrastructure from a cooperative agreement and the CHS Biospecimen Repository (N01HL268201800001C) to a single contract. In addition to study close out, the two scientific objectives are: 1) to maintain CHS as a research resource for the cardiovascular health of older adults; and 2) to deploy innovative approaches to assure the productive use of this infrastructure.